Path B Implementation of the FDA Produce Safety Rule in Delaware

PROJECT SUMMARY
Project Title: Implementation of the FDA Produce Safety Rule in Delaware.
Project Description: We intend to continue the implementation the FDA’s Produce Safety
Rule within Delaware by choosing program Path B. Continuing the success of this project will be
an effort through the Delaware Department of Agriculture along with the help of the University of
Delaware Cooperative Extension, Delaware State University Cooperative Extension, Delaware
Fruit & Vegetable Growers Association, as well as state agencies and extension in the
neighboring states. This plan will include education and training for produce farmers covered
under the rule, as well as a regulatory program which will include regulator training.
Project Goals: The project will develop a project plan for alignment of Delaware Department of
Agriculture’s regulations and activities with FDA’s Produce Safety Rule. Goals include improving
farm registration of covered produce farms, improving documentation, conducting routine
produce safety inspections providing farmers with education of, and training on, the Produce
Safety Rule, completing an assessment of Delaware Department of Agriculture’s regulatory
authority for produce safety and the resources needed to continue a successful program.
Expected Outcomes: We believe that the partnerships and plans that will emerge from the
work outlined in this proposal will create a federal-state relationship which will leverage the
existing expertise, knowledge and resources of the Delaware Department of Agriculture along
with the University of Delaware & Delaware State Cooperative Extension and regional state
partners within the Delmarva Peninsula, resulting in consistent and successful on-farm
inspections as envisioned by FSMA and the FDA.
Project Objectives:
1. Program Documentation
2. Program Administration
3. Education, Outreach and Technical Assistance
4. Farm Inventory
5. Inspection Program
6. Compliance and Enforcement
7. Produce Related Event Response Planning and Implementation
Budget: $350,000 for year one, $350,000 for year two, $350,000 for year three, $350,000 for
year four and $350,000 year for five, totaling $1,750,000 for the five-year grant period.

Public health relevance
PROJECT NARRATIVE The Delaware Department of Agriculture Produce Safety Rule, is applying for Path B, Funding Band 10 for the grant entitled Implementation of FDA’s Produce Safety Rule PAR-21-174, to continue the implementation of the produce safety program that encourages the safe production of fruits and vegetables and promote understanding and compliance with the FDA’s Produce Safety Rule in Delaware. The grant will continue our efforts to reduce the risks associated with covered produce related food borne illnesses, injuries, or death and ultimately protects the public’s health.